Program in Hematology: Molecular & Cell Biology of Blood Cells

PROJECT SUMMARY
This resubmission application requests continued funding for a postdoctoral research training program in
hematology that has been successful in attracting young scientists and physician-scientists into academic
careers in hematology and vascular biology. The program has as its primary objective to prepare MD,
MD/PhD, and PhD postdoctoral fellows for productive careers as academic scientists and physician-
scientists. The focus of training supported by this grant remains within the core scientific discipline of
hematology. We are requesting support for four postdoctoral trainees per year (two PhD trainees and two
MD or MD/PhD trainees), which is unchanged from the previous grant period. The training will be carried
out in an enriched environment of active basic, translational and clinical investigation at an institution that
emphasizes the career development and collaborative science. The specific objectives are: (1) To identify
and recruit outstanding postdoctoral trainees, of diverse gender, ethnicity and culture, who wish to obtain
comprehensive knowledge of the principles and techniques of basic and translational research related to
hematology, blood cells, vascular biology, coagulation, hematopoiesis, and immunobiology; (2) To attract
highly motivated scientists and physician-scientists and provide them with comprehensive instruction in the
design and implementation of high quality research projects, including participation in cross-disciplinary
research teams; (3) To train physician-scientists for academic careers in hematology and related scientific
disciplines and prepare them for successful transition to independent investigators; and (4) To expose
talented PhD scientists to the field of hematology and train them for careers as independent investigators
and research scientists. Since the last renewal, several new initiatives have been instituted. The curriculum
now includes core lectures in clinical hematology and required workshops in hematology research methods,
rigor and reproducibility, and grant writing. Mentoring committees and individual development plans are
required for all trainees. A structured mentoring plan for physician scientists has been developed since the
previous submission. The foundation of training continues to be centered on the individual mentored
research project, marked by a period of intensive, sustained research under the guidance of an established,
dedicated mentor. This training is supplemented and enhanced by didactic and mentored training
opportunities in team science and translational science, and by exposure to productive investigators
working in related areas, including scientists with expertise in basic biomedical science, genomics,
computational biology, and bioinformatics. The rich training environment provided by the diverse faculty,
extensive laboratory, clinical, and core facilities, and strong institutional support should ensure continued
success in attracting and preparing highly qualified postdoctoral trainees for careers in academic
hematology.

Public health relevance
PROJECT NARRATIVE This training program has as its primary objective to prepare young scientific investigators for productive careers in academic hematology and other research careers in hematology. There is a particular need to expand the number of scientists and physician-scientists trained in research in the field of hematology because of its direct relevance to some of the most common human medical conditions, including abnormalities of immune cells, vascular diseases, disorders of blood clotting, and cancers of blood cells.